Research Supplement to Promote Diversity in Health-Related Research Parent Project: Effects of Pregnancy and Postpartum Medicaid Dental Benefit Generosity On Use Of Dental Services

Project Summary:
The purpose of this pilot study is to explore postpartum women’s oral health knowledge,
attitudes, and behaviors (KABs) during and after pregnancy in Florida, and to identify specific
barriers and facilitators to dental service use, unmet dental needs, and the intent to use dental
services in the postpartum period. Oral health is integral to overall health, particularly for
maternal and infant health outcomes. Despite its importance, many women face barriers to
accessing dental care during pregnancy, such as financial constraints and lack of awareness,
leading to untreated disease and poor systemic health. This study addresses a gap in
understanding the specific oral health needs of postpartum women, especially given recent
policy changes expanding Medicaid eligibility for postpartum women in Florida.
This study addresses the oral health needs of postpartum women in light of recent Medicaid
policy changes in Florida that expand eligibility for this population. To capture diverse
perspectives, the study will develop and administer a survey in both English and Spanish,
targeting Florida’s growing Hispanic population, which represents 26.4% of the state’s residents,
with 22.2% identifying Spanish as their primary language. By including Spanish-speaking
participants, the study aims to provide more nuanced insights into the factors influencing dental
service use. Data will be collected from postpartum women at UF Health Shands Hospital
through anonymous surveys. The study will analyze key barriers and facilitators to dental
service utilization, unmet needs, and intent to seek dental care postpartum, while examining
relationships between socio-demographic and clinical factors and oral health KABs.
The findings will inform larger-scale studies and interventions, including a planned focus group
study, and provide preliminary data for a career development award application by Dr. Cilia
Zayas. This pilot study will lay the groundwork for developing strategies to improve dental health
outcomes for a diverse postpartum population in Florida.

Public health relevance
PROJECT NARRATIVE Oral health during pregnancy and postpartum has significant impact on a woman’s overall health, birth outcomes and their child’s oral health. This study will provide evidence on how the generosity of state Medicaid dental benefits during pregnancy and postpartum impacts access to routine and emergent dental care. Understanding the effects of dental benefits generosity and duration is critical to inform policy decision-making and implementation of recent expansions of Medicaid dental benefits for pregnant and postpartum women aimed to improve maternal health outcomes.